ACTG 360-- PROSPECTIVE STUDY OF HIV WRT CMV BURDEN ENDORGAN DISEASE

Prospective, multicenter, obseervational study of HIV infected subjects who are CMV seropositive with no clinical symptoms of CMV. Three year followup at 8 week intervals will establish onset of CMV endorgan disease or death. Relation of HIV load, CMV load and CMV endorgan disease will be studied.